Neisseria gonorrhoeae central metabolism in the context of neutrophilic inflammation

ABSTRACT
Neisseria gonorrhoeae (Gc) is the causative agent of the sexually transmitted disease gonorrhea. Gc is a
prominent threat to human health due to emergence of “superbug” strains that are resistant to all current
antibiotics and its clinical sequelae, including infertility and chronic pelvic pain, that have severe and lifelong
effects. Gc is highly adapted to colonize human mucosal surfaces, where it survives despite initiating a robust
inflammatory response and influx of polymorphonuclear leukocytes (PMNs or neutrophils) that typically clear
bacteria. We recently used the unbiased, genome-wide approaches of transposon-sequencing and dual RNA-
sequencing of Gc and PMNs to identify a cohort of genes contributing to successful Gc infection of PMNs. Gc
metabolic genes were overrepresented in this cohort, suggesting that Gc utilizes distinct metabolic pathways to
circumvent human mucosal defenses. We have applied this information to systems biology approaches to
generate a preliminary metabolic network reconstruction for Gc. This analysis leads to the prediction that Gc
utilizes specific host-derived metabolites to fuel its metabolism – in particular, lactate. PMNs are highly glycolytic
and consequently secrete lactate. Lactate can be consumed by Gc and is known to stimulate Gc glycolysis. Thus
we hypothesize that Gc exploits PMN metabolism, specifically lactate secretion, to survive at mucosal surfaces.
In this proposal, we will identify the central carbon metabolic pathways used by Gc in the presence of neutrophils,
using a combination of metabolite analysis, metabolic modeling, and bacterial genetic knockouts in Gc metabolic
enzymes. We will then test the necessity of these metabolic pathways in Gc for enhancing bacterial survival from
neutrophils and the underlying mechanisms, including modulating neutrophil antimicrobial responses, changing
Gc sensitivity to neutrophil antimicrobial components, and/or circumventing host nutritional immunity, or
modulating neutrophil antimicrobial responses. Together, this proposal will address key gaps in knowledge of
the fundamental metabolic processes of Gc during infection that are likely to have major impacts on outcomes
of gonorrhea.

Public health relevance
PROJECT NARRATIVE Neisseria gonorrhoeae is the causative agent of the sexually transmitted infection gonorrhea, which impacts nearly 87 million people worldwide each year. The US Centers for Disease Control and Prevention has named N. gonorrhoeae an urgent threat due to rising antibiotic resistance, the lack of a protective vaccine, and an ineffective immune response that fails to clear the infection or initiate protective immunity. The proposed research will investigate the metabolic pathways that N. gonorrhoeae utilizes and requires to survive human innate immune insults during infection, which can uncover potential anti-microbial targets for treating this disease.